Non-Invasive Diagnosis of Pediatric Pulmonary Invasive Mold Infections

Invasive mold infections (IMI) are a leading infectious cause of death in immunocompromised patients. IMI
is most frequently diagnosed in the lungs of children with neutropenia or graft versus host disease (GVHD).
Initial clinical suspicion for a pulmonary IMI (PIMI) is often based on lesions identified by chest CT, categorized
as “possible PIMI”. Additional diagnostic testing is usually limited to invasive procedures with concerning risk
profiles. The objective of this study is to establish a comprehensive non-invasive diagnostic approach in a
prospective multi-center cohort of 300 children with prolonged neutropenia or GVHD that present with possible
PIMI. Establishing an accurate non-invasive diagnostic strategy could reduce morbidity from invasive
procedures and reduce time to appropriate antifungal therapy, resulting in a reduction in IMI mortality. To
accomplish this, we will leverage the International Pediatric Fungal Network, a unique multidisciplinary group of
55 worldwide sites and the only such group dedicated to pediatric invasive fungal disease. This study will benefit
from an unparalleled collaboration with the Children's Oncology Group (COG), the world's largest organization
devoted to pediatric cancer clinical trials. In Aim 1, we will investigate a comprehensive non-invasive diagnostic
testing approach to confirm the presence or absence of proven or probable PIMI in children with newly identified
possible PIMI. We hypothesize that a non-invasive diagnostic strategy using available blood-based assays
(galactomannan, Aspergillus PCR, and Mucorales PCR) will provide positive and negative post-test probabilities
that are clinically informative. In Aim 2, we will leverage this cohort to compare the outcomes for children with
possible PIMI managed with empiric antifungal therapy vs. an invasive diagnostic procedure followed by
management based on results. Comparison will be using an outcome score measure that incorporates both
negative and positive consequences of each exposure, providing a balanced measure of the impact of a clinical
decision. We established a minimum clinically important difference (MCID) to dichotomize outcome into
`success' or `failure' from surveying experts in clinical mycology. We hypothesize that patients receiving empiric
antifungals will have more successful outcomes compared to patients undergoing an invasive diagnostic
procedure. This cohort also offers the possibility to study novel non-invasive diagnostic tests not widely available.
Therefore, in Aim 3, in a subset of patients we will explore the host response to proven/probable PIMI using
RNA-Seq to define transcriptional signatures, and assess plasma cell-free DNA/RNA next-generation
sequencing to detect mold pathogens. At select sites, we will also use breath testing to assess volatile metabolite
signatures as a marker for IMI. In summary, we will establish the utility of a new comprehensive non-invasive
diagnostic approach for possible PIMI using a panel of assays in a unique multi-center prospective pediatric
cohort. We will also compare, for the first time, the outcomes of children managed empirically vs. undergoing
invasive procedures. These results will provide the foundation for new evidence-based pediatric guidelines.

Public health relevance
NARRATIVE: Invasive mold infections are a leading infectious cause of death in immunocompromised children. We will use the International Pediatric Fungal Network to prospectively study three available blood-based diagnostic assays as well as study newer modalities to define risk factors for developing disease. The goal of this study is to define a novel non-invasive approach for earlier and accurate diagnosis of invasive mold infections in children in order to improve overall survival.